CORE--MACROMOLECULAR SEQUENCING AND SYNTHESIS FACILITY

The Macromolecular Sequencing and Synthesis Facility prepares oligonucleotides and sequences DNA and thereby enables Cancer Center members to carry out their research dependent on these techniques. A Perkin-Elmer Applied Biosystems 380B and 394 DNA synthesizers are used to prepare the oligonucleotides. A Perkin-Elmer Applied Biosystems robot catalyst is used to prepare the dye-labeled DNA fragments, and two Perkin-Elmer Applied Biosystems 373 A DNA Sequencers are used to do the sequencing.